Project 1 Melnick

PROJECT 1: ABSTRACT
One of the critical unmet needs from both the scientific and therapeutic standpoints in the B-cell lymphoma field
is understanding how these tumors evade the normal checks and balances of the immune system they arise
from. A majority of B-cell lymphomas arise from the germinal center (GC) reaction, during which B-cells undergo
extensive and rapid shifts in epigenetic programming, including transient suppression of immune signaling
receptors involved in forming synapse-like interactions with GC T-cell subpopulations. Notably, the genetic
hallmark of these tumors are somatic mutations in epigenetic regulatory genes, among which those affecting the
histone acetyl-transferase CREBBP and the histone methyltransferase KMT2D are the most common, and
moreover are highly co-occurrent. Prior work from our group showed that KMT2D and CREBBP mutations have
a tumor suppressor effect and function by disrupting gene enhancer activity. In both cases this led to aberrant
and persistent repression of different sets of immune synapse genes. More recently, we have explored the
manner in which CREBBP and KMT2D mutations might cooperate to drive lymphomagenesis and have made a
series of surprising preliminary observations, such as finding that these proteins engage in biochemical synergy
at gene enhancers, and that their disruption seems to reprogram the immune microenvironment in ways not
previously known to occur. Such data lead us to hypothesize that KMT2D and CREBBP mutations result in
profound and cooperative suppression of a broad range of immune synapse genes, distinct from those affected
by either mutation alone. We postulate that KMT2D and CREBBP form a complex at key regulatory enhancer
and superenhancers with their combined loss disrupting the epigenetic and architectural state of the target genes
in such a way as to prevent their response to immune synapse signaling leading in turn to reprogramming of GC
immune microenvironment. Specifically, we propose that this is due to induced differentiation of specialized T
follicular helper cells into T follicular regulatory (TFR) cells, which support expansion of GC B-cells, prevent their
differentiation, and suppress T-cell mediated immune surveillance. Ultimately this leads to an immune
suppressive environment that prevents entry and activation of cytotoxic CD8 T-cells. Finally, we we predict that
therapeutic approaches specifically inhibiting the aberrant TFR axis in KMT2D/CREBBP lymphoma will enable
more effective and rationally designed combinatorial immunotherapy approaches for the successful treatment of
these tumors especially when coupled with epigenetic therapies that restore the aberrant chromatin
programming induced by CREBBP and KM2D mutations. Hence the outcome of this proposal aside from the
novel mechanistic findings, will be the implementation of rational multi-layer regimens that will restore immune
eradication of these tumors.

Public health relevance
PROJECT 1: NARRATIVE This proposal explores how somatic mutations in chromatin modifier genes synergize to alter the epigenetic and 3D genomic landscapes of B-cells to drive formation of profoundly immune-evasive lymphomas. Specifically, the investigators will identify the basic mechanism through which the common CREBBP and KMT2D enhancer regulatory proteins synergize to drive lymphomagenesis and engage in aberrant cross-talk with T-cell subpopulations. Based on their mechanistic discoveries they will develop novel therapeutic regimens aimed at restoring the functionality of the immune system and making these tumors vulnerable to immune eradication.